Placental Proteins and Prematurity

PROJECT SUMMARY/ABSTRACT
Each year, 12-18 million infants worldwide, representing ~10% of all births, are born preterm (before 37 weeks
of gestation). The mechanisms underpinning preterm birth are poorly understood and, with the possible
exception of progesterone in a limited number of women, no interventions are currently available to prevent
preterm labor. The management of the preterm infant has improved over the last 30 years, however despite this
progress, prematurity remains the second most common direct cause of death among children under 5 years of
age. In addition, infants born preterm are at risk of neonatal morbidity (e.g., intraventricular hemorrhage,
bronchopulmonary dysplasia and necrotizing enterocolitis) and long-term sequelae including chronic lung
disease, retinopathy and poor neurodevelopmental outcomes. Emerging evidence in animal studies show that
factors secreted by the placenta are critical for normal fetal organ development. One of the most fundamental
differences between fetal and postnatal life is the instantaneous discontinuation of the umbilical circulation at
delivery, depriving the premature infant of placental factors, such as proteins, critical for fetal organ development.
We reported that 434 proteins are secreted by the placenta into the fetal circulation before 32 weeks of gestation.
Remarkably, a substantial number of these proteins could be linked to processes such as angiogenesis,
pulmonary development and neurogenesis, suggesting that a subset of these proteins are critical for the normal
development of fetal organs that are often injured in premature infants. Inresponse to PAR-23-130 Translational
Research in Maternal and Pediatric Pharmacology and Therapeutics, we will test the central hypothesis that
supplementation with candidate human placental proteins, i.e., that are secreted into the fetal circulation and
associated with the development of the brain, lung, retina, intestine and cardiovascular system, improve
outcomes in premature guinea pigs. Our approach will be to induce preterm delivery in guinea pigs, provide them
with 24/7 support in a guinea pig neonatal intensive care unit. Pups will either receive a single candidate human
placental protein or vehicle by a subcutaneous mini-osmotic pump for 7 days after preterm delivery. We propose
three aims: Aim 1: Determine the effect of candidate human placental proteins on mortality and short-term
respiratory outcomes in premature guinea pigs. Aim 2: Establish the effect of candidate human placental
proteins on short-term neurodevelopmental outcomes in premature guinea pigs. Aim 3: Determine the effect of
candidate human placental proteins on long-term lung and neurodevelopmental outcomes in premature guinea
pigs. Our proposal is conceptually highly novel because it represents a shift in the paradigm of how to approach
prematurity by supplementing with placental proteins supporting organ development. This work may lead to a
specific novel intervention that will alleviate perinatal mortality and morbidity and long-term sequelae in extremely
premature babies and that is scalable and universally applicable.

Public health relevance
PROJECT NARRATIVE Prematurity (being born before week 37 of pregnancy) and its complications are the number one cause of death of babies in the United States and despite improvement in care, babies who survive premature birth often have long-term health problems, including cerebral palsy, intellectual disabilities, chronic lung disease, blindness and hearing loss. Thus, prematurity is a problem of profound public health impact that requires a new way of thinking and the development of innovative approaches. In this project we will test the idea that the premature baby is deprived of placental proteins that are critical for the development of their brain, lung and cardiovascular system and administration of some of these proteins to premature pups in an animal model improve outcomes.